Spectral Components of Abnormal Spontaneous Gamma Activity in Schizophrenia and Translational Mouse Models

Spontaneous activity in the gamma band (~30-100 Hz) of the electroencephalogram has been related to the
balance of excitation to inhibition (E/I) in the cortex (Sohal & Rubenstein, 2019). Manipulations of E/I balance
by means such as optogenetic stimulation of pyramidal cells or inhibitory interneurons (e.g., Yizhar et al.,
2011), and blockade of N-methyl-D-aspartate receptors (NMDARs) on parvalbumin-expressing inhibitory
interneurons (e.g., Carlén et al., 2012) or pyramidal cells (Tatard-Leitman et al., 2015), have been shown to
alter the degree of spontaneous gamma activity (SGA). As such, SGA has come to be used as an index of E/I
balance in studies of neuropsychiatric disorders (e.g., Hirano et al., 2015; Picard et al., 2019). However, the
neural mechanisms underlying SGA have received relatively little focus.
Recent research has suggested that some kinds of neural activity that appear to be constant across
time and/or frequency are actually composed of brief bursts of oscillations that occur at different times and
frequency bands across trials (e.g., Jones, 2016). Furthermore, there is evidence that these oscillatory bursts
play functional roles in information processing (e.g., Lundqvist et al., 2016). However, the extent to which
alterations in SGA are due to changes in gamma bursts or other aspects of the power spectrum are unknown.
Previously we reported that SGA was increased in individuals with schizophrenia (SZ) compared to
healthy controls during auditory steady-state stimulation (Hirano et al., 2015). Further analyses revealed that
increased SGA in SZ was most closely related to the increased power of gamma bursts (Spencer et al., 2023).
Thus, alterations in SGA could reflect changes in particular aspects of gamma-generating circuits, which might
be attributable to specific neural circuit abnormalities and information processing mechanisms.
We will analyze previously collected data from humans and mice in our laboratories to further
investigate how components of SGA might be altered in SZ and in optogenetic and pharmacological
manipulation of cortical E/I balance in mice. Our specific aims are:
Aim 1: To determine if increased SGA in the ketamine and BF optogenetic models is due to the same
changes in SGA components as increased SGA in SZ. We will decompose SGA in the mouse baseline state
during ketamine administration and BF PV stimulation into burst parameters and spectral slope. We predict
that increased SGA will be primarily associated with increased gamma burst power and not other measures.
Aim 2: To determine if cognitive deficits in SZ and in mice during BF PV neuron stimulation are similarly
associated with increased SGA and gamma burst power. We will decompose SGA in human visual oddball
task data and in the novel object recognition task (NORT) in mice. We predict that reduced performance in the
oddball task in SZ and in the NORT in mice during BF PV neuron stimulation will be associated with increased
SGA, primarily because of increased gamma burst power.

Public health relevance
This project will study how components of spontaneous gamma activity (SGA), which indexes the balance of excitatory and inhibitory activity in the cortex, are related to cognitive function and symptoms in a neuropsychiatric disorder (schizophrenia) and to cognitive function in optogenetic and pharmacological animal models relevant to schizophrenia.